Career Enhancement Program

PROJECT SUMMARY/ABSTRACT of the Career Enhancement Program (CEP)
Our Translational Research Program in Colorectal Cancer Disparities' (TRPCD) Career Enhancement Program
is an essential component of our SPORE. Its primary purpose is to attract and support new scientists from
different disciplines (clinical, basic science, and population science) to the field of translational cancer disparities
research. This will be accomplished through achieving the following specific aims:
1. Research support: Foster collaborations that engage junior, mid-level, and senior investigators who wish
to enhance or refocus their careers on translational cancer disparities research by providing research funding
and complementary scientific expertise to pursue novel disparities research projects.
2. Mentorship and Sponsorship: Using a structured approach, provide all investigators engaged in the CEP
with appropriate mentors to help advance their pursuit of translational cancer disparities research.
Additionally, we will identify individuals within each investigator's institution who can serve as sponsors and
provide guidance and opportunities to help enhance their careers.
3. Leadership development: A critical national need is efforts to diversify the leadership of the nation's NCI-
designated cancer centers. We will provide leadership development opportunities for CEP participants with
a particular emphasis on women, underrepresented minorities (such as those prioritized in our TRPCD
research, Alaska Native, African American, and Hispanic people), and individuals with disabilities.
4. Recruitment and Retention: Through engaging in processes for new investigator/faculty recruitment and
leveraging strategies for investigator retention in each of our participating institutions, we will support the
recruitment of new investigators focused on translational cancer disparities research and facilitate retention
of investigators conducting this type of research.
The CEP will be coordinated between FHCC, the Alaska Native Tribal Health Consortium, Cedars-Sinai Medical
Center, and Ochsner Health. Recruitment of candidates will be conducted across all sites, and tailored career
enhancement programs will be developed to meet the needs of each awardee. Cornerstones of our program
include identifying and providing multi-disciplinary mentors, assigning sponsors, and providing opportunities for
leadership development as appropriate. Consistent with our SPORE's overarching values, the CEP will actively
seek to support scientists from underrepresented backgrounds. The number of scientists we can support has
been further enhanced through designated institutional funds from FHCC to double the funding level of our CEP.

Public health relevance
PROJECT NARRATIVE of the Career Enhancement Program (CEP) Our Translational Research Program in Cancer Differences across Populations (TRPCDP) Career Enhancement Program is an essential component of our SPORE. Its primary purpose is to attract and support new scientists from different disciplines (clinical, basic science, and population science) to the field of translational research aimed at meaningfully reducing long-standing differences in cancer incidence and mortality across population groups and identifying factors that drive differential outcomes among population groups. Cornerstones of our program include identifying and providing multi-disciplinary mentors, assigning sponsors, and providing opportunities for leadership development as appropriate.